RESEARCH TOPICS IN COMPUTER SCIENCE

Various storage and retrieval algorithms have been studied. The development of flexible and efficient storage and retrieval algorithms is very useful, because such algorithms are used in almost all computer programs. Thus, biomedical computation in particular can benefit from improved storage and retrieval methods. In FY85, work continued on the analysis of trie data structures and the development of algorithms and analysis for a new type of doubly-chained trie capable of holding prefixes. This work is of particular import for text storage and retrieval, including dictionaries, indices to document collections, and various special thesari. The proposed data structure provides a general mechanism for storing arbitrary words and/or phrases without restriction on content. The storage scheme is fast and parsimonious, and the retrieval scheme is also fast. Prior to discovering how to handle prefix items, tries could not be as easily employed for arbitrary collections of words.